EFFECTS OF INHALED FLUTICASONE PROPRIONATE VERSUS PLACEBO IN ADULT ASTHMATICS

Double blind randomized comparative trial assessing the efficacy and safety of inhaled fluticasone proprionate versus placebo in adult asthma patients.